COMPREHENSIVE DAY TREATMENT FOR PREGNANT DRUG USING WOMEN

The purpose of this five year randomized trial of an neighborhood based comprehensive day treatment for pregnant illicit drug users is to determine whether random assignment to a comprehensive, multidimensional program is better when compared to control women who receive standard care.